MULTICENTER NETWORK OF NEONATAL INTENSIVE CARE UNITS

This continuation application demonstrates all the necessary elements for our Center to remain a Network member. The extensive publication record provides unequivocal evidence of sustained productivity both within and beyond the Network. Our ability to design protocols, recruit patients, analyze and interpret data and effectively collaborate with other Network centers, the Data Center, and NIH is evident. There are 11 Board certified academic neonatologists permitting protected time for Network activities by investigators. Over 1000 newborns, including approximately 200 with birthweight <1.5 kg, are admitted annually. The obstetric service, including many high risk patients, will exceed 5000 deliveries this year. Four Maternal-Fetal specialists with interest in clinical research and committed to the Network are on staff. Our State Designated Level III perinatal Center includes state-of-the-art facilities for Neonatal Intensive Care and the newly constructed labor and delivery suites have central fetal monitoring. There is a full complement of pediatric medical and surgical subspecialists together with strong nationally recognized programs in respiratory therapy, nursing, genetics, nutrition, radiology, pediatric pathology, and pharmacy. There are an array of laboratories including biochemistry, hematology, immunology and microbiology, and a full service blood bank. The Radiology Department is replete with facilities for standard radiography, ultrasound, CT scanning, HRI and MR angiography, plus PET scanners. Our follow-up program is nationally acclaimed and boasts in excess of an 85% follow-up rate. The established computerized neonatal/ perinatal and follow-up data systems have supported a number of studies. We maintain timely and accurate transmission of data to the Data Center. The experienced nurse coordinator and clinical research nurse team ensure high enrollment rates and strict compliance with protocols. There is a firm divisional, departmental and institutional commitment to participate in a collaborative manner with other centers. CWRU has performed with distinction and is strongly desirous of continued participation in the Network. We accept the budgetary process. In summary, we once again satisfy all criteria for selection into the Network. We have documented a resolute intention to participate, a broad patient base, outstanding facilities, committed experienced personnel, computerized neonatal/ perinatal database, firm institutional backing, academic productivity, and the ability to collaborate well with our Network colleagues, hence satisfying all Network selection criteria.